MATERNAL ZINC STATUS DURING LACTATION AND GROWTH OF BREAST FED HUMAN INFANT

To determine the effects of variations in maternal zinc intake, within the framework of the recommended dietary allowance on maternal zinc status, milk zinc concentrations and infant growth.